Excitability Dysfunction Mechanisms Underlying the TDP43-Dependent ALS and FTD Pathogenesis

Project Summary/Abstract
Despite much effort to identify mechanisms underlying amyotrophic lateral sclerosis (ALS) and frontotemporal
lobar degeneration dementia (FTLD or FTD), effective treatments remain elusive. Motoneuron (MN) excitability
dysfunction remains the most tightly linked to ALS disease pathology. Much research has reported on disease
alterations in the excitability mechanisms of MNs. However, these data often conflict, as hyperexcitability,
hypoexcitability, and normal excitability have all been seen in animal models of ALS. Such inconsistent data
obscure the role of these excitability changes (i.e., neuroprotective or detrimental). Most of these conflicting
reports are seen in mutant super-oxide dismutase (SOD) models of ALS, the most commonly studied mouse
model of ALS. Our data obtained (via our active grant) from the aggressive G93A SOD mouse model of ALS
suggests that both hypo- and hyperexcitability disease changes might take place concurrently within diseased
MNs. Here, we propose to examine a recent, novel rNLS8 mouse model that recapitulates pathologic
Transactive-response DNA-binding Protein 43 (TDP43) inclusions seen in upper and lower MNs in >90% of ALS
patients, leading to neuronal loss in the brain and spinal cord. TDP43 is specifically seen in most sporadic-onset
ALS cases; thus, between them, the G93A and rNLS8 models represent most ALS, and also FTD, cases.
However, to date, excitability dysregulation has not been examined in this model. Thus, our objective is to
characterize the novel rNLS8 TDP43 mouse model of ALS and compare this data to our existing data from G93A
mice. Both models demonstrate very different disease scenario and progression, yet ultimately both lead to MN
loss and death. By comparing and contrasting mechanisms of excitability dysregulation between these models,
we expect to parse the roles that individual alterations play in ALS/FTD disease pathology via 3 Specific Aims:
Aim 1: Determine MN and synaptic excitability in the rNLS8 model. It is currently unknown whether MN
excitability is altered in the rNLS8 model – as in other ALS models – and whether synaptic excitability dysfunction
is also involved. Thus, we will measure intrinsic MN and synaptic excitability in the rNLS8 model via
electrophysiology recordings, at early, middle, and late disease stages, then contrast them to G93A data.
Aim 2: Determine the roles of ion channels and synaptic inputs in the death of spinal MNs in rNLS8 mice.
We will measure expression levels of ion channels and synapses in spinal MNs of rNLS8 mice at early, middle,
and late disease stages, then contrast them to G93A data.
Aim 3: Determine the roles of ion channels & synaptic inputs in the death of cortical neurons in rNLS8
mice. Loss of cortical neurons in rNLS mice recapitulates key aspects of ALS-comorbid FTD. To examine if
excitability mechanisms involved in the death of spinal MNs are also involved in FTD dementia, we will measure
expression levels of ion channels and synapses in cortical/subcortical neurons of rNLS8 mice at early, mid, and
late disease stages.

Public health relevance
Project Narrative Despite much effort to identify mechanisms underlying amyotrophic lateral sclerosis (ALS) and frontotemporal lobar degeneration dementia (FTLD or FTD), effective treatments remain elusive. Motoneuron (MN) excitability dysfunction is tightly linked to disease pathology, yet to date, excitability dysregulation has not been examined in the recent rNLS8 mouse model, which recapitulates pathologic TDP43 inclusions seen in MNs in >90% of ALS patients and in FTD patients. This proposal is relevant to public health because it will examine excitability dysregulation in this highly relevant model of ALS/FTD.